iDAPT Health Equity Supplement: An environmental scan of outer and inner context and social determinants of health among ISC3 Centers

Project Abstract Social determinants of health (SDOH) have critical implications for shaping health and health inequities in cancer incidence, morbidity and mortality. The Implementation Science Centers in Cancer Control (ISC3) are uniquely positioned to evaluate the SDOH that drive these disparities and ultimately identify implementation strategies to reduce them. SDOH shape the Outer Context (i.e., broader sociopolitical environment) that affect communities, health systems, and its residents. The Inner Context (i.e., healthcare systems) is uniquely positioned to identify and address SDOH to improve patient care and cancer outcomes. The purpose of this Administrative Supplement is to advance health equity through implementation science using environmental scans and cross- site collaboration. Specifically, we will (1) partner with all ISC3 centers to conduct an environmental scan of Outer Context common data elements to better understand the sociopolitical context that drives cancer-related disparities; and (2) collaborate across two Centers (Wake Forest iDAPT ISC3 and UPenn ISC3) to measure Inner Context SDOHs within cancer care delivery settings. Results from this administrative supplement will facilitate multi-site pilot implementation studies that improve the measurement and mitigation of SDOH to improve cancer care outcomes and health equity.

Public health relevance
Project Narrative Eliminating cancer-related disparities requires coordinated efforts across multiple stakeholders and contexts. The purpose of this ISC3 Health Equity Administrative Supplement is to advance health equity through implementation science using environmental scans and cross-site collaboration. The environmental scan will elucidate the social determinants of health within the Outer and Inner Contexts of the ISC3 Centers. These contexts focus on the broad sociopolitical environments and cancer care delivery systems. The long-term goal is to create cross-site collaboration in measuring SDOHs to foster implementation science solutions to reduce cancer-related disparities..